Data-driven Precision medicine in sepsis

DESCRIPTION (provided by applicant): The purpose of this K23 proposal is to provide Vincent Liu, MD, MS with the protected time and resources to pursue the additional training needed to reach his long-term goal of improving hospital outcomes through the innovative use of complex clinical data. Dr. Liu is a board-certified intensivist and Research Scientist at the Kaiser Permanente Division of Research (KP-DOR). The proposal builds on his background in critical care, traditional biostatistics, and the applied use of highly-detailed electronic medical record data. It also leverages the rich training environment afforded by KP-DOR, advanced didactic training in casual inference and informatics at Stanford University, and a cohesive mentorship team to improve our understanding and treatment of sepsis. Sepsis, the inflammatory response to infection, affects millions of patients worldwide each year and is the most expensive cause of hospitalization in the United States. In severe cases, more than one- third of sepsis patients die in the hospital and a growing population of sepsis survivors face increased mortality and disability rates after discharge. Recent randomized controlled trials (RCTs) have failed to identify efficacious therapies for sepsis and, more than a decade after its original description, we still await three multi- center RCTs designed to definitively demonstrate the benefits of a promising therapy-early goal-directed therapy (EGDT). In light of the challenges of designing and conducting RCTs in sepsis, novel approaches that leverage highly granular observational data from real-world practice are urgently needed to: (1) provide novel insight into sepsis disease mechanisms; (2) link the pathophysiology of sepsis to new interventions; and (3) offer improved disease prognostication for clinicians and patients. This project outlines such an approach. Its training aims are designed to expand skills and knowledge by: (1) optimizing our ability to predict adverse outcomes in sepsis patients after initial triage and treatment; (2) assessing whether EGDT can benefit patients with less severe sepsis; and (3) quantifying the specific impacts of acute organ dysfunction on long-term outcomes among sepsis survivors. The proposed work has high potential to make a significant clinical impact, as these aims will not only advance our understanding of disease mechanisms in sepsis, but also provide preliminary data on putative risk factors to target in future interventional trials. This work will also converge in a R01 proposal aimed at designing a real-time sepsis risk prediction tool. Furthermore, this K23 develops specific examples in sepsis whose logical extension to other critical care syndromes indicates applicability beyond the scope of this proposal and, hence, high public health significance. Importantly, the proposed work is realistic and feasible within the award period and will allow Dr. Liu to continue to build research skills, generate preliminary data, create additional collaborative relationships, and compete for R01 funding. In summary, this K23 award will support and accelerate the career development activities of Dr. Liu and allow him to successfully launch into the next phase of his career as an independent investigator.

Public health relevance
PUBLIC HEALTH RELEVANCE: Sepsis affects millions of patients worldwide and is the most expensive cause of hospitalization in the United States. Despite this, we still lack a comprehensive understanding of how sepsis affects hospital and long-term mortality. This project is designed to develop advanced methods for using detailed electronic medical record data to improve our understanding and care of sepsis patients.